Path C Continued Development of the NHDAMF Produce Safety Program Under Path C for Implementation of the FSMA Produce Safety Rule

NH PATH C PAR-21-174
Project Summary/Abstract
Project Title: Continued Development of the NHDAMF Produce Safety Program under Path C for the
Implementation of the FSMA Produce Safety Rule
The New Hampshire Department of Agriculture, Markets & Food (DAMF) began development of its’ Produce
Safety Program (PSP) in July 2018. The DAMF PSP Mission is to ensure: the safe production of quality
produce; assure producer competitiveness in the marketplace; and establish a unified partnership with FDA
to achieve an integrated food safety system.
Updated State law and rules have been developed, and legislatively approved, giving DAMF authority to
implement and enforce an inspection program, which verifies relevant stakeholders’ compliance to the FSMA
Produce Safety Rule (PSR). Agency laws and rules are publically available for produce growers covered under
the PSR.
Subject to sufficient federal funding, DAMF has legal authority to enforce the Food Safety Modernization Act,
Public Law 111-353, codified at 21 U.S.C. section 301 et seq., for standards of growing, harvesting, packing,
and holding of produce for human consumption, 21 C.F.R. Part 112, as incorporated by reference including
any subsequent amendments thereto.
(See links to State Law and Rules below)
Currently, DAMF has not conducted any sprout inspections under Subpart M of the PSR.
The Produce Safety Program (PSP) includes qualified inspection staff, possessing knowledge, and skills to
address state and federal FSMA regulations as defined by FSMA inspection protocols, tools and other relevant
practices.
DAMF’s PSP program provides educational and technical assistance to produce farmers covered under the
rule, and robust training of regulators.
FDA’s current CAP funding opportunity PAR-21-17, if awarded, would allow DAMF to continue developing the
program manual with procedures, policies and SOPs, that effectively establish a well-defined and strong
produce safety inspection program.
RSA 426-A Produce Safety:
http://www.gencourt.state.nh.us/rsa/html/NHTOC/NHTOC-XL-426-A.htm
AGR 3900 Produce Safety Farm Inspections:
http://gencourt.state.nh.us/rules/state_agencies/agr3900.html
1

Public health relevance
NH PATH C PAR-21-174 PROJECT NARRATIVE The New Hampshire Department of Agriculture, Markets and Food (DAMF) project titled: Continued Development of the NHDAMF Produce Safety Program under Path C for the Implementation of the FDA Produce Safety Rule is intended to support and build upon the current Produce Safety Program (PSP) in the state of New Hampshire. The DAMF PSP Mission is to: Ensure the safe production of quality produce; assure producer competitiveness in the marketplace; and establish a unified partnership with FDA to achieve an integrated food safety system. DAMF will utilize federal funding to support this project and facilitate the success of achieving the mission goals. Through continued program development, education and training, along with enforcement and compliance, we anticipate that NH’s stakeholders will have the tools to safely produce, harvest, pack or hold fresh produce, which in turn, will build public confidence in the safety of NH’s food systems.